Design, Data and Biostatistics Core

The Design, Data and Biostatistics Core (DDBC), previously known as the Methodology, Data Management
and Analysis Core (MDMAC), is an integral part of the UM Pepper Center. The primary goal of DDBC is to
provide methodological, data management, and analytical support to UM Pepper Center affiliated investigators,
that address the focus of the UM Pepper Center – to improve understanding of how metabolic factors,
infections, and inflammation interact with age-related diseases and comorbidities to determine key health
outcomes related to mobility and functional status of elderly people - as well as aging research in general. In
collaboration with other UM Pepper Center Cores, DDBC will improve the quality of UM Pepper Center
research studies, help foster development of junior researchers, will nurture forming interdisciplinary research
groups, and ultimately enhance quality of research on late-life processes. DDBC faculty will address the
following four aims: 1. Advise and assist UM Pepper Center investigators in methodological design, and
analytical tasks in conducting research projects; 2. Training and mentoring for UM Pepper Center investigators;
3. Facilitate the access of UM Pepper Center investigators to secondary survey and administrative research
data sets used for observational population research; 4. Undertake a limited number of internal efforts/projects
to identify in existing literature or develop novel methodological approaches, and implement and disseminate
them as software tools.